Light therapy for obsessive-compulsive disorder: A circadian medicine approach

PROJECT SUMMARY/ABSTRACT
Obsessive-compulsive disorder (OCD) is characterized by intrusive, distressing thoughts (i.e., obsessions) and
repetitive behaviors (i.e., compulsions) and is associated with significant functional impairment. Despite
established first-line treatments, non-remission and relapse rates following treatment are high (e.g., ~50%),
suggesting the existence of unidentified and untreated mechanisms in OCD. Prior work linking delayed
circadian rhythms to OCD suggests this may be one such mechanism and represent a novel treatment target.
Light therapy is a behavioral treatment that advances circadian rhythms and has been shown to be effective for
reducing symptoms of disorders that are phenomenologically similar to OCD (i.e., posttraumatic stress
disorder; Tourette’s disorder). Light is the primary zeitgeber, or environmental time cue, of human circadian
rhythms, and light exposure also has direct effects on brain regions implicated in psychopathology. However,
no study to date has tested the efficacy of light therapy for OCD. This project will address this gap in the
literature by comparing the efficacy of light therapy (n=20) versus placebo light therapy (n=20) for OCD
symptom reduction in adults with OCD+delayed bedtimes and examining change in circadian phase as a
mechanism. We will also examine photic sensitivity and habitual light exposure patterns in adults with
OCD+delayed bedtimes compared to healthy controls (n=25). Participants will complete 2 weeks of baseline
sleep and OCD symptom monitoring followed by a baseline dim light melatonin onset (DLMO) and photic
sensitivity assessment. Participants will then be randomly assigned to the active or placebo treatment condition
and complete 5 weeks of treatment. OCD symptoms and DLMO will be reassessed at the end of treatment.
We will examine whether OCD symptoms improve in the active treatment condition compared to the placebo
treatment condition and whether change in symptoms is associated with advanced circadian phase. We will
also examine whether adults with OCD+delayed bedtimes exhibit heightened light sensitivity and maladaptive
habitual light exposure patterns (lower daytime, higher evening light). Results from this study will inform
whether delayed circadian rhythms can be targeted for OCD symptom reduction. Through this project, I will
complete transdisciplinary training in clinical trials in circadian medicine, advanced methods in light
measurement and photic sensitivity, longitudinal modeling, and professional development, service, and
scientific writing. This project will also provide me with preliminary data to be competitive for an R01 to facilitate
my transition to independence.

Public health relevance
PROJECT NARRATIVE There is a critical need to identify novel modifiable behavioral targets to improve treatment outcomes in obsessive-compulsive disorder (OCD), as only 40% of those treated with a first-line treatment remit, and 59% of those who remit subsequently relapse. Based on accumulating evidence implicating delayed circadian rhythms in OCD, the proposed project will test the efficacy of light therapy (including morning bright light and evening dim light) for OCD in adults with OCD+delayed bedtimes and examine photic sensitivity and habitual light exposure patterns in adults with OCD+delayed bedtimes compared to healthy controls. This project will provide me with training in the necessary clinical translational sleep and circadian medicine skills for a long- term research program in understanding the role of delayed circadian rhythms in OCD etiology and developing a novel, scalable treatment that can be easily incorporated into existing first-line treatments to improve treatment outcomes in OCD.